Sudden Death Risk Assessment and Mechanistic Insights in Arrhythmic Mitral Valve Prolapse Using Cardiac MRI and Circulating Proteomic Biomarkers

Project Summary:
Mitral valve prolapse (MVP) is a common valvulopathy affecting 2-3% of the population and nearly 200 million
individuals globally. While it is often benign, a subset of patients with MVP may develop arrhythmias, including
sudden cardiac death (SCD). Although the association between MVP and SCD was first reported decades ago,
the risk was initially believed to be small; contemporary observational studies suggest that SCD may be a more
common sequela in MVP, with an estimated yearly incidence between 0.4 and 1.9%.
The National Heart, Lung, and Blood Institute recently convened a workshop composed of subject matter experts
and stakeholders to identify research needs and opportunities to develop recommendations for the identification
and treatment of individuals with mitral valve prolapse, including such individuals who may be at risk for sudden
cardiac arrest or sudden cardiac death.
Our current proposal is designed to align closely with the priorities identified in the recent NIHBI workshop.
Specifically, our proposal has three aims: 1) perform deep phenotyping of patients with MVP to understand
characteristics and mechanisms associated with ventricular arrhythmias; 2) Study a blood biomarkers panel
(including FDA-approved and novel high throughput proteomic markers) that could be used as a sensitive, costeffective
screening strategy to identify MVP patients with myocardial fibrosis who are at risk for SCD; 3) Build a
novel SCD risk prediction model in MVP inclusive of CMR evidence of myocardial fibrosis by assembling a large
observational multicenter MVP registry with over 2,000 contrast-enhanced CMRs and longitudinal follow-up for
arrhythmic events.

Public health relevance
Project Narrative: Mitral valve prolapse is a common valvulopathy affecting 2-3%; while it is often benign, a subset of patients with MVP may develop arrhythmias, including sudden cardiac death. There are currently no good risk assessment tools for the infrequent but devasting consequence of sudden cardiac death. This project will utilize cardiac magnetic resonance to 1) study patients with mitral valve prolapse to characterize morphologic features associated with arrhythmic risk; 2) develop and validate a blood biomarker screening strategy to identify patients who may benefit from cardiac magnetic resonance imaging; 3) form a large multicenter observational registry to develop a risk prediction model for sudden cardiac death in patients with mitral valve prolapse.